Administrative Support

Core B (Administrative): Program Director/Principal Investigator: Moore, John P / Moore, John P Abstract The objective of the Administrative Core is to support the performance of the research outlined in this HIVRAD application. The Core will be directed by the Principal Investigator, John P. Moore, PhD, and will be located in the Department of Microbiology and Immunology at the Weill Cornell Medical College, New York, NY. A succession plan for the HIVRAD group is outlined within the Administrative Core. The Core will coordinate all the operations of the HIVRAD team, and ensure that the overall goals of the research team are carried out by the Project Leaders. The Core will also ensure that all necessary administrative and support services are provided to the Research Project Leaders to further their work. The Core will liaise with the Medical College's administration to put in place inter-institutional agreements and sub-contracts, involving all the academic institutions involved, and with the team's extensive network of external collaborators. The Core will coordinate the creation and maintenance of the Patent Plan, the Public Access to Data Plan, the Sharing Research Resources Plan and any other relevant plans that affect the overall governance of the HIVRAD group. The Core will facilitate the obtainment of specialist research reagents for the use of the Research Project Leaders. This will involve making any appropriate and necessary arrangements for the provision of reagents from collaborators via Material Transfer Agreements or other legal agreements. The Core will liaise with the Internal Steering Committee and the Scientific Advisory Board, to make arrangements for conference calls, for the annual meeting, and for any other meeting that may be called by the Principal Investigator, the Co-Principal Investigator or the Project and Core Leaders. The Core will maintain a database of critical information derived from the individual projects, and it will assist with the publication of research papers as and when such a service is requested. The HIVRAD team's internal publication policy is located within the Administrative Core. The Core will coordinate the submission of annual Progress Reports to the NIAID, and will be responsible for any re- budgeting or carry-over requests that may be necessary during the course of this award. In summary, the Core will ensure that the research program outlined in this application is administered efficiently, allowing the Core and Project leaders to focus on accomplishing their individual and collective scientific goals.

Public health relevance
Core B (Administrative): Program Director/Principal Investigator: Moore, John P / Moore, John P Narrative The overall objective of this multi-site HIVRAD application is to help develop a preventative HIV-1 vaccine based on the induction of virus neutralizing antibodies by rationally designed, structurally relevant envelope glycoprotein trimers. Core B will coordinate and fulfill the administrative functions of the HIVRAD team, allowing the scientists involved in Projects 1 and 2 and Core A to accomplish their goals, which are highly relevant to public health and human welfare.